Muscle Cell Biology, Pathophysiology, and Therapeutics

Abstract
This proposal is a competitive renewal application for a multidisciplinary training program in basic and
translational research in muscle cell biology at UCLA from a group of highly engaged faculty mentors. The
program in Muscle Cell Biology, Pathophysiology, and Therapeutics is focused on bridged training in the fields
of muscle and numerous complementary fields and is the sole UCLA training program integrating fundamental
laboratory-based research in muscle relevant fields with preclinical and clinical applications. The Muscle
Research Center @UCLA is the hub of muscle focused research and educational activities. For many years, the
muscle research community at UCLA has been galvanized by funding from two major center grants including
the NIH P30 center grant and the NIH U54 Senator Paul D. Wellstone Center of Excellence grant that have been
vital to the recruitment of new faculty members from different fields to apply their expertise to skeletal muscle
diseases. Our trainees are further developed through activities of a top scoring, NIH-funded Clinical Science
Translational Institute (CTSI). A multitude of unique, interactive, and highly integrated activities in muscle
research serve as an outstanding resource for our trainees. The training program emphasizes training in the
cellular, molecular, and genetic mechanisms of basic muscle function and disease. At both the pre- and
postdoctoral levels, the Muscle Cell Biology, Pathophysiology, and Therapeutics main goals are to: 1) identify
and support outstanding trainees with a high level of interest and focus in muscle cell biology research, 2) train
scientists to conduct cutting-edge research in fundamental and clinical muscle biology, 3) provide trainees with
a solid background in the biological sciences with an emphasis in fundamental physiology, immunology,
biochemistry, biology, genetics, and now also stem cell biology and genomics, 4) facilitate career development
by helping trainees obtain extramural support, and by guiding trainees in obtaining positions in academia and
industry and other areas that suit their interests and skills, 5) introduce novel and significant projects for which
beneficial outcomes will be derived, 6) acquaint trainees with state-of-the-art research through the training grant-
supported fundamental and muscle relevant seminar series and associated journal clubs, and 7) provide trainees
with regular opportunities to present their own research in seminar form and receive critical feedback from the
training grant faculty and scientific community beyond UCLA at muscle and muscular dystrophy-related national
and international meetings, and 8) implement assessments as part of a larger campus effort to develop tools for
T32 training programs. UCLA has become a major site for preclinical and clinical trials in muscle disorders, using
a variety of innovative approaches. The Neuromuscular Program at UCLA in partnership with the Center for
Duchenne Muscular Dystrophy (CDMD) at UCLA has supported over twenty clinical trials in neuromuscular
disorders. Thus, trainees are exposed to both basic and clinical aspects of muscle disease research, providing
a well-rounded educational experience.

Public health relevance
Project Narrative The field of muscle cell biology muscular dystrophy translational research is expanding as academic and industry partnerships are yielding new potential treatments that are undergoing assessment in the clinics. Well-trained and highly motivated investigators in this field are essential for the progress of basic and translational muscle cell research as there have been major breakthroughs in mechanisms of disease and the emergence of new potential therapies for muscle disease. Trainees of the Muscle Cell Biology, Pathophysiology, and Therapeutics Program will fulfill its stated mission by advancing to positions of leadership in academia or industry and continuing to uncover basic principles in mechanisms of disease while also developing next-generation therapies based in muscle diseases for the betterment of patients and their families.